Systematic Genetic Dissection of Human Erythropoiesis

Project Summary/ Abstract
Our lab has made substantial strides in understanding how human genetic variation affects erythropoiesis and
fetal hemoglobin (HbF) levels, both critical factors in conditions such as sickle cell disease and β-thalassemia,
as well as other forms of anemia. Utilizing cutting-edge genetic studies, we have mapped thousands of genetic
variants influencing red blood cell phenotypes and HbF levels. We have also functionalized these variants
through the use of innovative techniques such as massively parallel reporter assays and base editing in primary
human hematopoietic stem and progenitor cells that were developed with support we received over the past ten
years from this grant. In this competitive renewal application for this foundational grant, “Systematic Genetic
Dissection of Human Erythropoiesis,” we propose a deeper investigation into the genetic network regulating
human erythropoiesis and HbF expression. Specifically, we aim to 1) use massively parallel base editing to
pinpoint key nucleotide determinants of HbF-related regulatory elements; 2) chart high-resolution interaction
maps between these regulatory elements, their target genes, and other interactive genomic elements across
different stages of erythropoiesis; and 3) conduct multiplexed base editing of key transcription factors and
identified regulatory nucleotides to understand their genetic interactions. Our research will provide invaluable
insights into the intricate genetic mechanisms regulating erythropoiesis and HbF expression, potentially paving
the way for innovative therapeutic approaches for hemoglobinopathies. This project signifies a critical
foundational step in leveraging genetic knowledge for the development of clinical interventions in debilitating
hematological conditions.

Public health relevance
NARRATIVE Our lab is advancing knowledge of how human genetic variation influences the production of red blood cells and a special form of hemoglobin called fetal hemoglobin (HbF), which can help in conditions like sickle cell disease and other forms of anemia. Using state-of-the-art genetic tools, we aim to uncover the complex network of genes that control red blood cell production and HbF levels, which could lead to new, innovative treatments for blood diseases. This research marks a key step towards turning our genetic understanding into tangible clinical solutions for challenging blood disorders.